Cancer Research Career Enhancement and Related Activities

ABSTRACT – CANCER RESEARCH CAREER ENHANCEMENT AND RELATED ACTIVITIES
The UWCCC has been committed to fostering the careers of cancer researchers since its founding by Dr.
Harold Rusch in 1972. From its inception, the UWCCC has worked to educate students, physicians, and the
people of Wisconsin about cancer: both its causes and its treatments. It has also worked to guide its
researchers to understand cancer at all levels and to develop practical treatments for this disease. In this
section, we outline the two major drivers of our Cancer Research Career Enhancement: 1) How we have and
shall educate the next generation of Cancer Experts; and (2) How we have and shall educate our catchment
about the practical concerns with cancer as a disease.
The new Associate Director of Faculty Development and Education has investment spending authority in
UWCCC’s educational mission (approximately $250 - $500K/yr). We are requesting an additional $145K in this
CCSG proposal. This investment will accomplish the following: 1) match training opportunities with several NCI
and NIH training awards held at UW-Madison; 2) rigorously train a diverse clinical and translational workforce
at all levels; 3) foster career development opportunities at all levels of UWCCC’s scientific workforce including
pilot and bridge funding for UWCCC’s young investigators; and 4) promote UWCCC's efforts to develop cancer
education throughout the state of Wisconsin.
UWCCC success in training cancer investigators is outstanding. Research education continues to be a high
priority. This success is exemplified by the breadth and reach of our academic faculty and funding of our
members. UWCCC members are committed educators in the pre-doctoral programs in Cancer Biology, Cell
and Molecular Biology, Molecular and Cellular Pharmacology, Genetics, Biotechnology, Molecular
Biosciences, Nutrition, Environmental Toxicology and other areas. UWCCC's commitment to fostering the
careers of basic cancer researchers is matched by its commitment to promoting the careers of its clinical
faculty. Through their respective departments, the UWCCC clinical faculty educate young physicians in a full
range of clinical fellowship programs including medical oncology, hematology, pediatric oncology, radiation
oncology, pathology, gynecologic oncology, and surgical oncology (including the surgical subspecialties). We
enrich our programs with weekly seminars, specific forums for doctoral and postdoctoral student presentations,
and grand rounds including; UWCCC’s weekly Grand Rounds, the McArdle weekly Colloquia, and DOT case
conferences. UWCCC member(s) organize these symposia, which directly relate to our Scientific Programs.